1/3 A randomized controlled trial of frozen embryo transfers performed in modified natural versus programmed cycles (NatPro)

Administrative Request Project Summary
In the United States, approximately 75% of the 368,000 assisted reproduction cycles performed
annually involve frozen embryos. Multiple studies have suggested an association of frozen embryo
transfer (FET) with an increased risk of hypertensive disorders of pregnancy, such as preeclampsia.
It is critical that this risk be minimized because preeclampsia is associated with severe short- and
long-term consequences for both mother and infant. What is needed is a rigorous, prospective,
randomized controlled trial where women undergoing IVF are randomized to cycles with and without
the presence of a corpus luteum (CL). NatPro was funded by NICHD as a linked R01, randomized
clinical trial in September 2019 designed to definitively answer the question: are hypertensive
disorders of pregnancy reduced when FETs are performed in a natural cycle with a CL, when
compared to a programmed cycle without a CL? Unfortunately, the launch of NatPro coincided with
the COVID-19 pandemic and, in accordance with government recommendations in March 2020, IVF
clinics were shutdown leading to a delay in initiation and enrollment for the study. After the COVID-
19 restrictions were lifted, NatPro has steadily enrolled study subjects at a rate very similar to its
original plan. However, due to the initial, unforeseen recruitment delay caused by the pandemic,
completion of the study within the 5-year funding period will require an increased pace of enrollment.
The goals of this administrative supplement are two-fold: 1) to rapidly increase the number of study
recruitment sites to substantially increase the enrollment pace; and 2) to increase personnel to enable
completion of the study with the planned enrollment targets. Together, these two measures will allow
the NatPro leadership to “bend the curve” and accelerate the pace of enrollment and complete the
study within the funding period. Completing the NatPro Study in a timely manner is of the utmost
importance because the negative health outcomes associated with preeclampsia, affecting both
mother and child, may be minimized by the findings of this study and the resulting procedures used
prior to embryo transfer. While the study is at 53% of planned enrollment, if there is no change in the
pace of enrollment, the sample size is very likely to be insufficient to make definitive
recommendations for patients and providers. If the study is carried to completion, however, the
findings are likely to form the basis for clinical guidelines affecting the 368,000 women each year in
the US that rely on IVF to build their families.

Public health relevance
Administrative Supplement Project Narrative NatPro is a randomized clinical trial to determine whether a pregnancy resulting from an embryo transfer in programmed cycle is less likely to have an increased risk of preeclampsia compared to embryo transfer in a “natural” cycle. The key objective of this administrative supplement is to increase the pace of enrollment and augment clinical sites to accelerate accrual that was delayed because of the COVID-19 pandemic.